Administrative, Education, and Analytic Support Core

Alcohol consumption is an important modifiable cardiovascular disease (CVD) risk factor among people living
with HIV infection (PLWH). Given that alcohol use is common among PLWH, and CVD is a leading non-AIDS
disease and cause of death among PLWH, addressing alcohol consumption in this population is critically
important. The Microbiome, mETabolites, and Alcohol in HIV to reduce CVD Program Project Grant (PPG) is a
multidisciplinary group of investigators with expertise in alcohol, HIV, gut microbiome, biomarker research,
nutrition, and randomized controlled trial (RCT) design. Our overarching hypothesis for this P01 application
is that among PLWH, a probiotic can mitigate alcohol associated dysbiosis and lower levels of microbial
translocation, inflammation, and improve metabolite profiles (Project 1); and that harmful levels of these
metabolites are associated with higher risk of CVD and death events (Project 2). To test this hypothesis, this
PPG will leverage the Veterans Aging Cohort Study, the Uganda Russia Boston Alcohol Network for Alcohol
Research Collaboration on HIV/AIDS, the Integrated Metagenomic and Metabolomic Core (IMMC) at the
University of Louisville Alcohol Research Center, and the Vanderbilt SCHolars in HIV and Heart, Lung, Blood,
and Sleep ReSearch NIH K12 junior faculty training program to accomplish these objectives: (1) To determine
if a probiotic tailored for alcohol associated gut dysbiosis mitigates this dysbiosis, microbial translocation,
inflammation, harmful metabolites, CVD and mortality risk (Project 1 RCT, Lead Freiberg); (2) To assess the
association between alcohol use, CVD and death via three metabolic pathways among PLWH (Project 2
Cohort, Lead So-Armah); (3) To provide metabolomic and biomarker laboratory resources (IMMC, Lead
Barve); (4) Administrative leadership and services to support the proposed research (Admin Core, Leads
Freiberg and Barve); and (5) Encourage and develop future trainees. The Administrative (Admin) Core will be
responsible for day-to-day management and functioning of the PPG. The Admin Core goal is to ensure that
the scientific and programmatic activities of the PPG are conducted per protocol in a timely fashion, within
budget, and with the highest quality. The Admin Core has these specific aims: (1) To provide administrative
oversight of the PPG, including assembling a steering committee, program advisory committee, and data
safety monitoring board, and developing the policies and procedures necessary to successfully organize and
complete our specific aims and training initiatives; (2) To provide services to PPG investigators and trainees
(e.g., study progress reports, compliance assurance, assistance with presentations and publications), and to
promote/disseminate the PPG'S work; (3) To provide resources (e.g., data and specimens), biostatistical
support, and mentorship to new investigators ; (4) To promote synergy within and across other funded PPGs;
(5) To monitor progress and compliance of the PPG's components, implement improvement mechanisms if
necessary, and assist investigators with challenges (e.g., recruitment).